Basic Immunology Training Program

PROJECT SUMMARY
The Duke University Graduate Program in Immunology proposes a continuation of its Basic Immunology
Training Program. The main objective of the Training Program is to select talented predoctoral candidates and
to prepare them, through formal coursework, seminars and independent research, for outstanding and
productive research careers in basic immunology. The training faculty consists of 32 immunologists who hold
primary or secondary appointments in the Department of Immunology. This faculty provides trainees with
opportunities for rigorous training in a range of areas of contemporary immunologic research, for example:
mechanisms of lymphocyte and myeloid cell development and function, including lineage determination, V(D)J
recombination, class switch recombination, somatic hypermutation, cell signaling, effector cell differentiation,
lymphocyte and myeloid cell homeostasis, immunological memory and immunological tolerance; mechanisms
of innate immunity and inflammation, including macrophage, dendritic cell, mast cell and complement function;
mechanisms of host defense against bacterial, viral and fungal pathogens; autoimmunity; anti-tumor immunity;
neuroimmunology; and vaccine development. Funds are sought to support the training of four predoctoral
students per year. A selections committee will choose the most outstanding second and third year predoctoral
trainees in the Graduate Program in Immunology for support by the Training Program. Special emphasis will
be placed on the recruitment and selection of outstanding underrepresented minority trainees. A carefully
crafted core curriculum will provide trainees with superb grounding in basic immunology, biochemistry, cell
biology, molecular biology and genetics. Trainees will receive formal training in research ethics to insure that
they will conduct their research with the highest standards of academic integrity. Trainees will also be provided
a range of career development opportunities so that they are best equipped to parlay their training into
productive and rewarding career paths.

Public health relevance
PROJECT NARRATIVE The Basic Immunology Training Program will teach the next generation of US researchers the critical skills they will need to perform outstanding basic immunologic research. Future discoveries by these researchers will be absolutely essential for our continued progress in the fights against infectious diseases, cancer, autoimmune diseases, and immunodeficiency diseases.